Clinician Scientist Training in Substance Abuse Research

[unreadable] DESCRIPTION (provided by applicant): Using the revised Mentored Clinical Scientist Development Program Award (MCSDPA) mechanism, the Division of Substance Abuse, Department of Psychiatry at Yale University School of Medicine requests a 3rd 5 year renewal for our Clinician Scientist Training Program, which has been providing intensive training in research methods for clinical and preclinical investigation of drug abuse since 1991. We request a continuation of 6 positions for faculty level Clinician Scientists to spend 3-5 years at Yale's Division of Substance Abuse obtaining clinical and research training under the mentorship of a team of 20 senior investigators whose interests range from molecular neurobiology to health services research. With over 40 externally funded research projects, the central theme of our research program is the development and evaluation of innovative pharmacological and behavioral treatments for substance abusers. Our multidisciplinary program enables us to conduct research that moves rapidly in both directions from preclinical projects ("bench") to clinical studies ("bedside"). The training goal for this program is to provide Clinician Scientists at the junior faculty level with an opportunity to devote virtually full-time effort during the initial phase of their careers to learning research skills and conducting research projects as a critical step toward launching careers as independent research scientists. After initial work conducted with the support of this program, they will be guided to develop scientifically meritorious research applications (using, for example, R03 and R01 mechanisms) which will provide support for research that extends beyond the period of the program. Since the onset of the program we have provided training for 22 Clinician Scientists, many of whom are among the leaders of their generation of drug abuse investigators. [unreadable] [unreadable] [unreadable]